Project 2

Project 2 (Koch)
SUMMARY/ABSTRACT
Studies have shown that the heart can secrete factors including those in extracellular vesicles (EVs)/exosomes
that can induce significant effects both locally to myocardial tissue and distantly to other organs. This includes
adipose tissue where data from our lab has revealed that the heart can secrete substances that can alter
adiposity, especially after a high fat diet (HFD). In fact, specific signals are released after HFD when adrenergic
signaling in myocytes is altered by manipulation of G protein-coupled receptor kinase 2 (GRK2) levels and activity
as increased myocyte GRK2 leads to a lean phenotype after HFD and myocyte-specific GRK2 inhibition leads
to an obese phenotype. This has been recapitulated in vitro with conditioned media experiments from myocytes
to cultured differentiating adipocytes. GRK2 regulates β-adrenergic receptors (βARs) in the heart where this
pathway is crucial for normal and compromised cardiac contractility and function. GRK2 is up-regulated in the
heart after cardiac stress, which includes HFD and increased GRK2 leads to compromised βAR signaling and
GRK2 is involved in heart failure (HF) progression. The GRK2-adrenergic signaling axis appears to be important
in the endocrine activity of the heart as well since we have uncovered data over the last cycle of this grant that
manipulation of GRK2 can have profound and significant effects on EV cargo including microRNAs (miRs). We
believe these EV/exosomes secreted from stressed hearts/myocytes with increased GRK2 could participate in
cardiac dysfunction locally. In addition to HFD, GRK2 can be increased in the hearts of mice by ischemic injury
and hypertrophic stress. Previous data and new data in this proposal not only shows that altering GRK2 in the
heart can have profound effects distantly on adipose tissue via what is secreted but also can affect local cardiac
cells in a paracrine fashion. In fact, increased cellular GRK2 results in increased GRK2 in secreted EV/exosomes
including after ischemic injury in vivo and these EVs have detrimental effects when placed on cultured cardiac
cells. Thus, manipulation of GRK2 in myocytes can significantly alter the myocardial secretome that appears to
have profound effects both locally and distantly including new data showing changes in fat depots after cardiac
injury in a sex-specific manner. Specifically, the Central Hypothesis of this proposal is that cardiac stressors,
which alters GRK2 levels and signaling can alter the myocardial secretome including the contents of
EV/exosomes, which can significantly affect myocardial injury and repair as well as influence regulation of distant
organs, especially adipose. Specific Aims are: [1] To identify factor(s) and elucidate novel mechanisms involved
in the communicative signals secreted from GRK2-altered myocardium responsible for regulating systemic
adiposity after HFD; [2] To determine the mechanistic role of altered myocyte GRK2 levels on EV/exosome
content and determine how GRK2’s up-regulation after injury alters EV-mediated myocardial responses; [3] To
determine the role of altered myocyte GRK2 levels and corresponding secreted EV/exosomes on the post-injury
regulation of distant adipose tissue acutely and chronically during HF development.

Public health relevance
Project 2 (Koch) Narrative (relevance): Elucidating novel roles for GRK2 and adrenergic regulation of secreted extra-cellular vesicles (EVs) and exosomes from myocytes and how this leads to changes in the secretome during heart failure and metabolic disorders will be critical to gain increased understanding of these disease processes. It is clear that the cardiac secretome (signals/factors released from the heart) can affect neighboring heart cells as well as distant organs such as fat cells and some of these crucial factors are packaged in EV/exosomes and levels of GRK2, which can be induced by stressors including ischemia and high fat diet, can alter what is secreted. Working with this PPG group will lead to elucidation of novel communicative signals between heart and fat that can lead to novel therapeutic targets not only for heart failure but also potentially for obesity.